Super-resolution Microscopy Study of Molecular Transport Mechanisms

PROJECT SUMMARY
We are writing to request funds to acquire the Olympus FV3000 confocal microscopy system from
Evident Instruments. This cutting-edge imaging system will be a valuable addition to the Yang
laboratory and will greatly enhance our ability to conduct research in the field of cell biology and
biophysics. The need for this high-end confocal microscope to support the NIH-funded research
in our laboratory described below is both urgent and increasing.
Our laboratory has developed unique tools that have enabled further progress towards
understanding molecular transport mechanisms involving three sub-cellular organelles in
eukaryotic cells: the nucleus, cytoplasm, and primary cilium. Macromolecular trafficking among
these compartments is suggested to be gated by two unique mechanisms. One is the nuclear
pore complex (NPC) embedded in the nuclear envelope that mediates bidirectional trafficking of
proteins and RNAs between the cytoplasm and the nucleus; the other is the transition zone (TZ)
located at the base of primary cilium that regulates the entry of membrane and cytosolic proteins
into the cilium.
Without access to a high-end confocal imaging system designed for researchers who require the
highest image quality and imaging versatility, some research questions in our research projects
cannot be answered. However, with this high-end confocal microscopy system, we can
immediately obtain large-scale 3D imaging of nucleocytoplasmic transport and cytoplasm-cilium
trafficking, which is urgently needed but not available in our laboratory now. Furthermore, this
new confocal imaging system equipped with the two-deck configuration of Olympus IX83 inverted
microscope is highly compatible with other imaging techniques currently existing in our
laboratory2. For example, with the unique two-deck configuration3, we will be able to integrate
epifluorescence microscopy, laser scanning confocal microscopy, total internal reflection (TIRF)
microscopy, SPEED microscopy and other super-resolution microscopy into a single vibration-
free platform. These advanced multifunctional features include 3D confocal imaging, single-
molecule tracking, spectral imaging, high-speed imaging, super-resolution imaging, and multi-
area time-lapse imaging allow us to capture dynamic biological processes in real-time and with
unprecedent high precision for the MIRA-funded reach projects including nucleocytoplasmic
transport and cytoplasm-cilium trafficking.

Public health relevance
We are writing to request funds to acquire the Olympus FV3000 confocal microscopy system from Evident Instruments. The need for this high-end confocal microscope to support the NIH- funded research in our laboratory is both urgent and increasing.